INHALED HUMAN INSULIN VS USUAL SQ INSULIN IN TYPE II DIABETES MELLITUS

Although human alveolar epithelium has long been known to be permeable to insulin, actual diabetes management by insulin administration via lung awaited development of a practical delivery system. A new dry powder insulin formulation and aerosol delivery device permits reproducible pulmonary delivery of rapid-acting insulin in therapeutic amounts with 1-2 inhalations per dose. To compare the safety and efficacy of a regimen using this inhaled insulin (INH) vs. a conventional injection regimen (SC), 51 patients with insulin-treated type 2 diabetes (NIDDM) from 10 sites were randomized, after a 1-month run-in, to either INH or SC treatment for 3 mo. SC group continued their pre-study insulin regimen (2-3 injections/day), while INH received pre-meal INH plus a bedtime Ultralente insulin injection. Baseline HbA- {1c} was 7.8 in SC and 8.7 in INH. QID home monitoring in all patients was reviewed weekly and insulin adjusted to target premeal glucose 100-160 mg/dl.